A PROSPECTIVE STUDY OF 1ST TRIMESTER USE OF BENDECTIN AND MALFORMATIONS

In this prospective study, 31,602 women were asked at their first prenatal visit about the use of Bendectin; 2,711 women reported use in the first trimester. The odds ratio for major malformations was 1.05(0.78 -1.40). When individual malformations were evaluated, Bendectin use was statistically associated with microcephaly (5.33(1.61-17.7)), cataract (5.33(0.98-29.1), and lung malformations (4.58(1.76-11.9)). Since it is not clear whether these associations are due to the use of Bendectin or to the indication (vomiting) for which the drug was prescribed, the association between vomiting and these malformations was studied using previously published data from the Collaborative Perinatal Project. In that study, vomiting was associated with microcephaly (3.3(1.1,9.8)) and cataract (3.5(0.8-16.1)). Vomiting was associated with these 2 malformations only among nonusers of Bendectin. Lung malformations were not associated with vomiting during pregnancy (1.3(0.8-2.1)). These data suggest that Bendectin does not cause these malformations; however, the possibility that vomiting is associated with microcephaly and cataract is supported.